7/8 NADIA U01 Recovery of Adolescent Alcohol Disruption of Basal Forebrain-Cortical Projection Circuits

Project Summary
The requested Research Supplement to Promote Diversity in Health-Related Research will
support the training of an outstanding Early Investigator developing an independent research
career in the field of developmental alcohol and later brain pathology. Heavy alcohol consumption
during adolescence is associated with persistent changes in brain structure, connectivity, and
adult hippocampal and cortical-mediated cognitive functions. Enduring pathological changes
consistently observed in rodent models of adolescent ethanol exposure (Adolescent Intermittent
Ethanol; AIE) include reductions of nerve growth factor, suppression of the cholinergic
phenotypes, changes in activity-dependent acetylcholine release, and blunted hippocampal
neurogenesis. The current Supplement to Promote Diversity extends the research scope of the
Parent Project by examining whether AIE increases amyloid-β (Aβ) hippocampal levels, serving
as a synergistic mediator of cellular pathology. At high levels, Aβ also binds to the p75
neurotrophin receptor, contributes to cell death, and may predispose the brain toward an
accelerated pathological response. Given that pathological Aβ release is activity-dependent, a
novel γ-aminobutyric-acid type-A receptor modulator (GABAAα5) will be used to correct AIE-
induced Aβ dysfunction. These research activities will expand the research experiences and
scientific scope of the candidate. Specifically, the research plan will expose the candidate to
developmental ethanol perspectives and several innovative technical approaches (in vivo brain
activity; programming, data science essentials). The mentoring plan will entail training in
equitable and inclusive mentoring and teaching, effective publication and grant writing, and
networking with leading researchers with expertise in developmental alcohol exposure and adult
neuropathology. Critically, the candidate will be exposed to an academic model that blends
teaching, mentoring, and research. Career development and mentoring plans are cohesively
devised to facilitate a successful transition to a tenure-track faculty position by the candidate.

Public health relevance
Project Narrative: Heavy alcohol consumption followed by periods of abstinence (i.e., binge drinking) during adolescence is a major contributor to both acute and chronic health issues. This proposal conducts mechanistic studies to understand how the brain pathology associated with adolescent binge drinking contributes to pathological aging process. This Research Supplement to Promote Diversity in Health-Related Research will support the training of an outstanding Early Investigator to develop an independent research and academic career that will reveal the processes that promote the increased risk for dementia following alcohol use disorder.